New Jersey Alliance for Clinical Translational Science: NJ ACTS

Project Summary/Abstract In response to NCATS NOSI: Clinical and Translational Science Award (CTSA) Program Administrative Supplements (NOT-TR-20-014), the New Jersey Alliance for Clinical and Translational Science (NJ ACTS)(UL1TR003017) propose to create a new position within its administrative team, the Manager of Quality Assurance and Quality Control. The NJ ACTS Manager for Quality Assurance and Quality Control will be responsible for quality reviews of CTSA-related submissions to NCATS, submissions to the ASSIST and NIH eRA Commons, and curate/monitor the overall process, including key personnel changes; KL2 projects; pilot projects involving human or animals, diversity or re-entry supplement scholars/trainees, foreign components, competitive and administrative supplements, and CTSA-related projects and initiatives, perform quality reviews of CTSA-related submissions to NCATS, submissions to the ASSIST and NIH eRA Commons, accomplish these goals, the QA/QC Manager will work among the NJ ACTS cores and services, participate in institutional and NJ ACTS committees, work with our partner academic institutions and interface with NCATS and other CTSA Consortium Hubs, The new position will not only enhance the services we offer within the NJ ACTS community by working directly with faculty, establishing process and checklists, and providing educational materials and training, the QA/QC Manager will improve the quality of prior approval submissions to NCATS, increasing the speed of our submissions, their completeness and quality and ultimately, improving the outcome of submissions to NIH and NCATS and program. This new position will directly impact our ability to initiate clinical and translational research, contributing to our shared mission.

Public health relevance
Project Narrative By establishing a position of Manager of Quality Assurance/Quality Control, the New Jersey Alliance for Clinical and Translational Science will be able to more efficiently and effectively fulfill the requires of, and receive prior approval from, the National Center for Advancing Translational Science and other components of the National Institutes of Health. The overall result will be that promising research will be initiated more quickly, fulfilling both the mission of NCATS, NIH and NJ ACTS to support science that can lead to discoveries that directly translate to improve treatments, diagnoses, policy changes and population health.